Acquisition of a Zeiss LSM 980 Confocal Microscope with Airyscan Capability

Project Summary
A user group of six major, and 5 minor, NIH funded investigators at Cold Spring Harbor Laboratory
(CSHL) request funding to purchase a state-of-the-art Zeiss LSM980 Confocal Microscope System with Airyscan
2 capability to dramatically extend the CSHL Microscopy Shared Resource’s ability to perform streamlined multi-
color fluorescent imaging with improved resolution in live or fixed cells and tissues in either confocal, spectral,
or Airyscan modes. This microscope system will help to rapidly advance existing research projects and will be
an invaluable tool for CSHL researchers seeking new collaborative and translational initiatives. The requested
system includes 6 laser lines (405, 455, 488, 514, 561, 639nm), 2MA-PMT+32 Channel GaAsP Detectors, an
Airyscan 2 Super Resolution Detector, Z-Piezo for fast Z-stacking, AI Sample Finder for Automatic Tissue
Detection and Sample Carrier Calibration, and a Live Cell Incubation Chamber including stage surround
incubation, temperature, CO2, and humidity control. These new and advanced imaging features will substantially
enhance the greatly needed imaging infrastructure at CSHL, enabling innovative research in cancer,
neuroscience, genomics/genetics, as well as in fundamental biology. The Zeiss LSM980 system will be used to
address immediate questions in the areas of Gene Expression, DNA Replication, Neural Circuits, Synaptic
Phagocytosis by Microglia, Cellular Mechanisms Underlying Developmental Disorders, Cellular Signaling, Breast
Cancer, Pancreatic Cancer and the Tumor Microenvironment. As directly described in the research sections
these studies will be greatly aided by the acquisition of the requested microscope system. Of particular note, the
requested instrumentation will be shared by researchers studying both basic biological processes as well as
cancer and neurological diseases, and its shared use will therefore promote exchange of ideas and state of the
art techniques between the research groups at CSHL. The studies that will be enabled using the requested
instrumentation are of direct relevance to public health in regard to cancer and neurological diseases.

Public health relevance
Project Narrative Innovative biomedical research depends on state-of-the-art microscopy with advanced multicolor fluorescence imaging in 3D and 4D, and improved resolution in either confocal, spectral, or Airyscan modes. Here we propose to acquire a Zeiss LSM980 Confocal Microscope with Airyscan2 capabilities. This instrument will meet a wide variety of microscopy needs across various Cold Spring Harbor Laboratory research areas, including cancer and neuroscience research that is directly relevant to advancing public health.